Understanding the role of mitochondrial specialization in early development

PROJECT SUMMARY
Embryogenesis is an energetically demanding process in which a single cell initiates divisions, giving rise to
progeny that undergo diverse cell fate decisions and complex morphogenetic behaviors to form a multicellular
organism with distinct tissues. Mitochondrial oxidative phosphorylation (OXPHOS) and subsequent ATP
production play a central role in meeting the dynamic energetic and ROS-mediated signaling demands of
embryogenesis. OXPHOS consists of four ETC complexes that each contain multiple protein subunits (~100
total). Importantly, when the function of ETC proteins is impaired, variable developmental defects occur,
suggesting that development is dependent on specific ETC proteins. However, how the mitochondrial ETC is
regulated to meet the varying energetic and signaling demands of development remains unclear because of
the vast complexity of the ETC and difficulty of studying the ETC in development. The Sherwood lab has
recently created the first in vivo mitochondrial ETC toolkit in C. elegans, through endogenous fluorophore
tagging of ~20 nuclear encoded ETC components from the four ETC complexes. Through whole embryo
analysis of fluorescence levels, I have found that ETC complex expression increases ~1.5-3 fold per
mitochondria from the two-cell to the two-fold stage when major tissues have formed. ETC protein levels differ
between the developing primordial tissues, with striking divergence in the increased levels of ETC proteins per
mitochondria in the epidermis compared to the intestine. Overall, this proposal will test the hypotheses that
unique mitochondrial ETC levels develop after tissue specification to meet the distinct energetic and possibly
signaling demands of the tissue and that these unique mitochondria are essential to tissue differentiation.
Completion of the proposed aims will develop C. elegans as a new model to understand mitochondrial ETC
regulation and specialization in development, which has important implications to our understanding of
development, mitochondrial biology, and metabolic disorders.

Public health relevance
PROJECT NARRATIVE The mitochondrial electron transport chain (ETC) is composed of over 100 different proteins and drives oxidative phosphorylation/ATP production, which is crucial in meeting the dynamic energetic demands of tissues during development. ETC dysfunction is associated with developmental defects in humans, yet the role of the mitochondrial ETC in development and how it is regulated is unclear. The proposed work will use the strengths of C. elegans cell biology and genetics to reveal the function and regulation of dramatic tissue-specific specialization of ETC composition during development, thus providing foundational insights into ETC remodeling and function in development and how ETC dysregulation contributes to human developmental disorders.